Minimally-invasive technology for personalized nutritional monitoring

Project Summary/Abstract
Monitoring and optimizing dietary intake are important for precision nutrition in the treatment of clinical
conditions (diabetes, obesity, kidney/liver failure, etc) as well as attenuating loss of muscle function and mass
during aging. However, current methods for personal health monitoring do not provide reliable measurement of
macronutrient intake or availability of metabolites after digestion. Thus, this project aims to address this gap by
developing multi-analyte sensing devices based on an innovative combination of insertable optical reporters,
wearable readers, and advanced computational methods. These devices will provide continuous/on-demand
measurement of metabolites in interstitial fluid (ISF), then use those measures to predict macronutrient intake.
The project is organized into three specific aims: Aim 1 will involve collecting blood samples and ISF samples
(via microdialysis) from healthy human subjects consuming fresh meals and then using machine learning
methods to establish a quantitative relationship between macronutrient intake and the resulting blood and ISF
levels of metabolites. Fresh meals will be designed by the investigators to have three different levels of protein
and carbohydrates. Data will be analyzed to establish quantitative relationships between compartmental
concentrations, identifying proportionality coefficients and temporal lag/lead parameters, and develop machine-
learning models to predict macronutrients in meals from the plasma and ISF concentrations of metabolites.
Aim 2 will proceed in parallel with Aim 1, focusing on modifying current oxygen and glucose-sensing devices to
measure amino acids. Extensive benchtop testing will be used to verify accuracy and precision of calibration
based on fusion of sensor data streams. Aim 3 will then focus on deploying and testing a removable version of
the multi-analyte sensing system in human subjects. Participants will be fitted with the sensors, a microdialysis
catheter, and a continuous glucose monitor. Subjects will consume fresh meals as well as macronutrient-
matched frozen meals, matched for contents, to verify that the system (sensors and algorithms) also work for
meals that are more representative of the diet for many Americans, especially in low-income communities. The
computational algorithms developed in Aim 1 will be used to predict macronutrient availability from sensor data
as well as microdialysis. Sex, skin color, and health indicators (BMI, HbA1c, etc) will be factored into analyses
to assess whether they substantially affect performance of instrumentation and algorithms.
This project will bring together a team of biomedical engineers, computer scientists, and nutrition & metabolism
researchers to develop instrumentation and collect data from human subjects that will yield: new knowledge
and insight on the relationship between nutritional intake and systemic metabolite levels (Aim 1); advances in
technology for sensing metabolites as nutritional biomarkers (Aim 2); evaluation of the sensing technology and
computational models in diverse human subjects consuming common meals. (Aim 3). Success in this project
will advance research on metabolism and support development of new approaches to personalized nutrition.

Public health relevance
Project Narrative This project aims to advance technology to monitor dietary intake in support of precision nutrition, which is important in managing many chronic conditions. An innovative combination of insertable and wearable devices with advanced computational methods is proposed to enable continuous or “on-demand” measurement of several metabolites and use them as nutritional biomarkers for estimation of macronutrient intake.